RED CELL ADHERENCE TO ENDOTHELIUM IN SICKLE CELL DISEASE

The goal of this research is to characterize the molecular mechanisms involved in the abnormal adherence of sickle red blood cells to vascular endothelium and/or subendothelial matrix proteins.